Deprescribing Decision-Making using Machine Learning Individualized Treatment Rules to Improve CNS Polypharmacy

ABSTRACT
Central Nervous System (CNS) polypharmacy is a cumulative exposure to 3 or more medications
with CNS-acting properties. CNS medications include anticholinergics, antidepressants, antipsychotics,
benzodiazepines, gabapentinoids, hypnotics, opioids, and muscle relaxants. A growing number of older
Americans are prescribed multiple CNS-acting medications and are affected by CNS polypharmacy,
which is rapidly becoming a wide-spread geriatric syndrome. CNS polypharmacy leads to adverse
outcomes such as physical and cognitive impairment and medication-related falls, serious injuries,
hospitalization, diminished quality of life, and even death. Deprescribing, the systematic process of
tapering or stopping medications, offers potential to reduce the burden of CNS medications. However,
deprescribing may also result in the exacerbation of underlying symptoms for which CNS medications
were originally prescribed. Existing guidelines, such as Beers or STOPP, do not take into consideration
the complex interplay of multiple medications and individual patient’s unique clinical characteristics, which
are necessary for individualized, patient-centered care. Essential are individualized deprescribing
solutions that account for these complexities.
This project will identify varying benefits and harms of deprescribing across individuals and
medications classes. We will then subsequently develop individualized treatment rules (ITRs) for
personalized medication discontinuation recommendations based on patients’ unique clinical
characteristics to support clinical practice. First, using causal inference methods, we will analyze
PCORNet multi-site electronic health record (EHR) data with linked Medicare claims data to quantify the
probability of medication discontinuation based on patients’ observed clinical characteristics. Then we
will employ supervised and unsupervised machine learning (ML) methods, such as decision trees and
clustering techniques, to accurately predict patient outcomes after medication class discontinuation
based on that patient’s unique clinical characteristics.
Our team will leverage prior experience in causal inference and machine learning applied to EHR
data to estimate deprescribing's clinical benefits and harms. We'll ultimately integrate these results into
a user-friendly clinical interface, ensuring trustworthy ML and transparent model decision-making
processes. As an initial step, we'll engage clinicians, patients, and community partners early in the design
phase to assess understanding and trust in ML-based deprescribing guidance. This will prepare us for a
future large-scale clinical trial to test the efficacy in achieving deprescribing goals.

Public health relevance
PROJECT NARRATIVE Many older adults use sedating medications for pain, anxiety, and mood, which can have harmful effects on their health. Deprescribing, a process that safely reduces or stops these medications, holds great potential to improve the well-being of older adults, especially if personalized and data- driven support is available. This proposal aims to enhance deprescribing efforts by 1) leveraging medical records and artificial intelligence to personalize deprescribing recommendations, and 2) examining factors that optimize doctors' and patients' understanding and trust in artificial intelligence-driven clinical guidance on deprescribing.